Molecular pathways of calcium pyrophosphate deposition disease

Calcium pyrophosphate deposition disease (CPDD) is a common type of arthritis defined by the presence of
calcium pyrophosphate (CPP) crystals in articular cartilage. While CPDD typically affects elderly patients in a
sporadic fashion, it also occurs prematurely in familial patterns. Studies of familial forms of this disease present
exciting opportunities to identify novel therapeutic targets for this currently untreatable arthritis. We recently
confirmed that a mutation in the stop codon of TNFRSF11B causes early onset CPDD. TNFRSF11B codes for
osteoprotegerin (OPG). OPG is a decoy receptor for Receptor Activator of Nuclear Factor Kappa B Ligand
(RANKL). RANKL promotes osteoclast formation. Our preliminary data clearly demonstrate that recombinant
mutant OPG (OPGmt) displays inefficient inhibition of RANKL resulting in excess osteoclastogenesis in vitro. Our
genetically engineered mice carrying OPGmt have osteopenia and premature arthritis mirroring the effects of
OPGmt in humans. We have also found that osteoclast conditioned media potently stimulates chondrocyte
pyrophosphate (PPi) production, a necessary process for CPP crystal formation. The purpose of this work is to
investigate the conceptually innovative hypothesis that OPGmt produces CPDD by increasing
osteoclastogenesis in subchondral bone. We propose that excess osteoclasts in subchondral bone stimulate
cartilage PPi production and that high cartilage-derived PPi levels target pre-osteoblasts to exaggerate
subchondral osteoclastogenesis seen in the presence of OPGmt. The scientific premise of this work stems from
careful observations of the phenotype of patients with OPGmt and strong preliminary data. In Aim 1 we will use
Opgmt/+ and Opgmt/mt knock-in mice to comprehensively determine the role of Opgmt in arthritis pathogenesis in
mice and determine if disease can be prevented by blocking RANKL. In Aim 2, we will employ in vitro and in
vivo models to investigate the role of high PPi levels in promoting OPGmt-induced arthritis and elucidate the
underlying mechanisms. This work is the first to identify the OPG/RANKL/RANK pathway in CPDD and to
implicate subchondral bone as a primary target tissue in this disease. This proposal includes a novel mouse
model that will serve as the basis for further mechanistic and pre-clinical studies in CPDD. The shared clinical
features of patients with the OPG mutation and those with age-related CPDD and the existence of available
drugs which target these pathways support rapid translation of this work.

Public health relevance
Calcium pyrophosphate deposition disease (CPDD) is a common and painful form of arthritis with no specific or effective therapies. Genetic abnormalities in a protein called osteoprotegerin were recently discovered to cause familial forms of CPDD. In this proposal, we characterize a novel animal model carrying this mutation and explore the mechanisms through which osteoprotegerin mutations cause CPDD with the ultimate goal of developing new therapies for this disease.